Structural and Drug Screening (SDS)

PROJECT SUMMARY/ABSTRACT (STRUCTURE AND DRUG SCREENING SHARED RESOURCE)
The Structure and Drug Screening Shared Resource (SDS-SR) provides services encompassing the key
elements of early-stage drug development through lead optimization. SDS-SR is a collaboration of Structural
Biology (SB), High-Throughput Screening (HTS), and Medicinal Chemistry (MC). SB, HTS, and MC frequently
coordinate services for Rogel Cancer Center (Rogel) members to increase the efficiency and impact of cancer-
related projects. SDS-SR enables Rogel members to use advanced structure-based drug design and/or
nonbiased HTS strategies to identify chemical matter that can be advanced through a milestone-driven research
plan resulting in efficient and effective discovery and development of precision oncology medicines - a strategic
goal of the Rogel Cancer Center. The overall goals of SDS-SR are to identify novel molecular targets for new
cancer therapeutics and to identify novel chemical leads and/or tool molecules that interact with these targets.
Our services start with refining the protein target via high throughput cloning and expression through confirmation
and optimization of hit binding via X-ray crystallography. Once the target is refined, it is purified in quantities
ranging from micrograms to grams for high-throughput screening (HTS) assay development and large scale HTS
for hit identification. Additional biophysical orthogonal assays are offered to determine whether the compound
binds directly to the target prior to structure determination. Rogel members are provided with training,
advisement, consultation, and specialized equipment through every step of the process. SDS-SR services are
provided by scientific staff with a breadth of expertise and backgrounds in both academia and industry. Many of
these services are not available through vendors or other institutions. SDS-SR continues to be an invaluable
resource to Rogel members. The SDS-SR’s cohesive activities, services, and processes ensure that projects
are advanced along the translational pipeline, from basic science discoveries into early cancer drug discovery.